Uncovering sleep and circadian mechanisms contributing to adverse metabolic health

Project Summary/Abstract
Obesity and diabetes have reached epidemic proportions in modern society, with treatments and comorbidities
costing billions of dollars in health care costs each year. Concurrent with increases in obesity and diabetes have
been decreases in the amount of sleep millions of Americans obtain on a nightly basis. Though associations
between short sleep and poor metabolic health are clear, exact mechanisms driving poor health are not well-
understood. For example, inducing sleep restriction inherently results in a number of confounding variables, most
notably circadian disruption, which also independently impairs health. It is thus difficult to develop targeted
interventions without first identifying the individual and combined effects of chronic sleep restriction and circadian
disruption on metabolism. The goal of this project is to systematically determine the influence of chronic sleep
restriction and circadian disruption, both independently and in combination, on metabolic health. Our specific
aims are to: 1) uncover the impact of chronic sleep restriction, circadian timing, and their combination on energy
intake patterns; 2) determine the influence of chronic sleep restriction on food choice when there is equal
opportunity to eat at all circadian times; and 3) uncover the impact of chronic sleep restriction, circadian timing,
and their combination, on glucose tolerance. To accomplish our aims, we have designed a 14-day randomized-
control mechanistic study in which participants will be either chronically sleep restricted or not while all activities
are scheduled to occur evenly across all circadian phases on a 20-h “day” with ad libitum food access. We
hypothesize that when individuals have equal opportunities to eat at all circadian times, they will 1) consume
greater amounts of calories during the circadian evening independent of sleep condition, 2) sleep restriction will
result in higher evening carbohydrate consumption, which will be associated with higher endocannabinoid
concentrations, and 3) chronic sleep restriction will result in more impaired glucose tolerance after circadian
disruption. These data will provide a fundamental understanding of how chronic sleep restriction and circadian
disruption impacts metabolic health. Importantly, these data will have far-reaching implications, particularly in
the development of interventions to promote healthy weight in not only individuals that are overweight/obese,
but also those at risk for obesity who live on short sleep schedules and/or work on extended duration, rotating,
or permanent nightshifts. This project also meets the following High-Priority Research Areas for future research
in the NIH National Center on Sleep Disorders Research (NCSDR) plan. Goal 1: Elucidate the Sleep and
Circadian Mechanisms Underlying Health and Disease, particularly in identifying sleep and circadian influences
on the biology underlying obesity and cardiometabolic risk in humans and to better tailor interventions in clinical-
translational studies, and Goal 2: Improve the Treatment of Sleep and Circadian Disorders and Reduce the Risks
Associated with Sleep Deficiency and Circadian Misalignment, particularly in elucidating the relationship between
circadian biology, sleep health, and the timing of food intake on cardiometabolic health and obesity.

Public health relevance
Narrative Obesity and diabetes have reached epidemic proportions in modern society, with great costs to health care systems. This proposal will uncover the influence of chronic sleep restriction and circadian disruption, both independently and in combination, on metabolic health. The findings from this project will inform the development of biological and behavioral interventions to promote healthy weight in not only overweight or obese individuals, but also individuals at risk for obesity who live on restricted sleep schedules and/or work on extended duration, rotating, or permanent night shifts.